Early Life B-cell and plasma cell development in the human Spleen: a new paradigm for lifelong immunity

PROJECT SUMMARY/ABSTRACT:
In ongoing experiments, we show that early-life antibody-secreting cells (ASCs), or plasma cells (PCs),
appear spontaneously in the spleen, not the bone marrow (BM), before birth. The splenic ASCs develop from
transcriptionally distinct fetal B-progenitors absent in adults. The splenic ASCs develop spontaneously in utero
and secrete public natural antibodies (NAb) highly shared across individuals. Notably, these naturally occurring
splenic ASCs secrete public NAbs with specificities against self, commensals, and common pathogens,
including encapsulated bacteria known to cause life-threatening infections in infants. Finally, the naturally
occurring ASCs upregulate survival genes similar to the long-lived plasma cells (LLPCs), suggesting they
persist throughout adulthood. These findings highlight the relevance of the spleen, separate from the BM, in
supporting the development and survival of B cells, ASCs, and NAbs that are protective against common
pathogens. We validated these findings using humanized mice and showed that fetal B-progenitors give rise to
long-lived mature B cells that survive >1 year and spontaneously differentiate into ASCs in the mouse spleen,
not BM, and secrete public NAbs that recapitulate the specificity of the shared clones in the human fetal
spleen.
Here, we will characterize early-life B-cell and ASC development and function (and compare them to
their adult counterparts) to uncover the mechanisms of adaptive immunity operating at birth. This will provide a
new framework for understanding human immune responses at different ages and reveal new targets to
modulate such responses. In three Specific Aims, we will test our hypothesis that the human immune system
comprises at least two developmentally and functionally distinct lineages (or layers) of B cells and ASCs—
early-life and adult. Aim 1 will focus on the B-cell development at different hematopoietic organs (liver and
BM) and determine the main cytokines and metabolic dependencies that regulate B cells in early life versus
adulthood. Aim 2 will characterize the phenotype and functions of the mature B-cell subsets and their
spontaneous differentiation to ASCs in the spleen before birth. This aim will reveal the mechanisms of B-cell
activation and metabolic reprogramming that lead to effector B cells, ASCs, and NAbs in early life. Finally, Aim
3 will focus on the antigen specificity and effector functions (glycosylation profile) of the public NAb repertoire
that spontaneously emerge in the spleen before birth. We will clone the top (> 500) antibody repertoire shared
across individuals to test their specificity against common pathogens, commensals, and self-antigens and
search for these clones in the adult spleen. These studies will greatly extend our knowledge of the B-cell and
antibody responses before birth and establish the human spleen, separate from the BM, as a unique reservoir
for the development and survival of public B cells, ASCs, and functionally glycosylated NAbs against self,
commensals, and pathogens known to cause life-threatening infections in children.

Public health relevance
PROJECT NARRATIVE We lack critical knowledge on how the human immune system functions in early life, particularly the B cells and antibody-secreting cells (ASCs), which are essential for protecting infants against life-threatening infections. Thus, we will characterize the differences between early life versus adult B cells, including the antibody specificities of the ASCs that emerge in the spleen before birth, revealing the unique mechanisms of humoral immunity at different ages. We expect our studies to reveal new targets to regulate antibody responses in early life, informing future vaccination strategies in children, and shedding new light on the mechanisms that lead to B-cell dysregulation in early life, including autoimmunity, leukemias, and immunodeficiencies.